Retrospective Autoimmune PAP Natural History and Patient-Reported Outcomes Study

ABSTRACT
Despite enormous advances in our understanding of autoimmune pulmonary alveolar proteinosis (aPAP), a rare disorder
of macrophage dysfunction, alveolar surfactant accumulation, and hypoxemic respiratory failure, no longitudinal studies
have defined its natural history, no clinical or patient-reported outcome measures have been validated in aPAP patients,
and no FDA-approved therapy is currently available. Currently, aPAP is treated by whole lung lavage, an invasive,
inefficient procedure requiring general anesthesia and mechanical ventilation that aims to physically remove the excess
surfactant by washing it out with up to 50 litters saline per lung. We elucidated the pathogenesis of aPAP, established an
accurate blood test for diagnosis now serving as the gold-standard, and participated in multiple clinical trials identifying
inhaled GM-CSF as a promising pharmacotherapy of aPAP. Notwithstanding, a poorly defined natural history (in terms of
disease progression) and lack of validated outcome measures are critical barriers to pharmacotherapeutic development.
The objective of this proposal is to use our existing US National PAP Registry to conduct a retrospective natural history
study of aPAP to define disease progression in terms of how patients, function, their treatment requirements and degree
of lung impairment; and to develop and test novel tools to measure and monitor changes in the severity of aPAP lung
disease. The central hypothesis is that defining the natural history of aPAP using an outcome measure incorporating how
patients feel, function, and breathe as a function of the severity of their lung disease and developing tools to measure
clinical outcomes will accelerate pharmacotherapeutic development for aPAP. The rationale for the proposed research is
that availability of information defining the natural history of aPAP and outcome measures reflecting how patients feel
and function (and quality of life) will accelerate pharmacotherapeutic development by providing more appropriate clinical
trial end points and knowledge how to interpret them. We plan to address this hypothesis in 3 Specific Aims: 1) conduct
of a retrospective, longitudinal, medical chart-based natural history study of aPAP; 2) develop and test a novel patient-
reported outcome measure - aPAP disease severity score (aPAP-DSS) that reflects how patients feel, function (and quality
of life), their requirement for supplemental oxygen therapy, and an objective measure of impairment in gas exchange (the
diffusing capacity of the lungs for carbon dioxide (DLCO%); 3) develop and test a novel patient-reported outcome measure
of aPAP disease severity (5-minute step test) better able to elicit/demonstrate the impairment in oxygen delivery than the
six-minute walk test. The proposed research is innovative because it represents a marked departure from existing
approaches (e.g., cross-sectional studies and use of clinical trial end points not validated in aPAP that don’t reflect how
patients feel, function, or survive) by defining the natural history, and developing and testing tools to measure disease
severity (aPAP-DSS) and remotely measure functional limitation (5-minute step test) expected to have less variability and
greater sensitivity than the 6-minute walk test. The proposed research will move the field forward because it will overcome
critical barriers to the development of pharmacotherapeutics for aPAP. Further, the novel tools to be developed/tested
may be useful for evaluation of lung diseases beyond aPAP, including a variety of rare and common lung diseases.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it will establish the natural history of autoimmune pulmonary alveolar proteinosis (aPAP) in terms of disease progression and develop and test new tools to measure disease severity and limitation in exercise capacity, remotely, and with improved sensitivity and less variability. Results are expected to advance the field by overcoming critical barriers expected to accelerate the development of new pharmacotherapies for patients with aPAP. Further, these novel tools are likely to be useful for evaluation of lung diseases beyond aPAP, including a variety of rare and common lung diseases.